GENETIC LESIONS RESPONSIBLE FOR TRIOSEPHOSPHATE ISOMERASE DEFICIENCY

Studies of the heterogeneity of the molecular basis of erythrocyte triosephosphate isomerase deficiency were performed using CDMAS.